Type IV Protein Secretion in Helicobacter pylori

PROJECT SUMMARY (ABSTRACT)
Helicobacter pylori is a Gram-negative bacterium that colonizes the human stomach. H. pylori colonization of the
stomach results in chronic gastric mucosal inflammation and is a strong risk factor for gastric cancer and
duodenal or gastric ulceration. Gastric cancer is the third leading cause of cancer-related death worldwide, and
H. pylori has been classified as a type I carcinogen by the World Health Organization. The H. pylori CagA protein
is secreted through a type IV secretion system (T4SS), enters gastric cells, and causes alterations in cellular
signaling associated with malignant transformation. CagA and components of the Cag T4SS are encoded by
genes within a chromosomal region known as the cag pathogenicity island (PAI), which is present in some H.
pylori strains but not others. The incidence of symptomatic gastroduodenal disease (gastric cancer or peptic
ulceration) is higher among individuals infected with cag PAI-positive strains than among those infected with cag
PAI-negative strains. The molecular architecture and protein composition of the H. pylori Cag T4SS differ
substantially from corresponding features of T4SSs found in other bacterial species. The overarching long-term
goal of this research is to develop a better understanding of the molecular mechanisms by which H. pylori causes
gastric disease. During the previous funding period, we isolated a transmembrane core complex of the Cag
T4SS containing five proteins encoded by the cag PAI, described three main structural features of the complex
(outer membrane cap, periplasmic ring and stalk), and built partial models of three proteins within the complex.
The aims of the current proposal are i) to build a complete structural model of the five Cag T4SS core complex
components; ii) to define structure-function relationships for CagY (a core complex component predicted to span
from the inner membrane to the outer membrane), elucidating its role in CagA recruitment and T4SS activity;
and (iii) to define actions of the Cag T4SS in vivo. Methods will include single particle cryo-electron microscopy
analysis of the T4SS core complex, specialized techniques for genetic manipulation of H. pylori, cell culture-
based assays of Cag T4SS activity, and an animal model of H. pylori-induced gastric cancer. These studies will
provide important advances in our understanding of the molecular mechanisms by which H. pylori infection can
lead to gastric cancer and other gastric diseases. On a broader scope, these studies will increase our
understanding of bacterial secretion systems and the delivery of bacterial virulence factors into host cells, as
well as molecular mechanisms underlying microbe-induced carcinogenesis.

Public health relevance
Project narrative A bacterium known as Helicobacter pylori colonizes the stomach in about half of all humans; most do not develop any symptoms related to this infection, but some develop stomach cancer or peptic ulcer disease. Stomach cancer is the third leading cause of cancer-related death worldwide and H. pylori infection is the leading cause of stomach cancer. The long-term goals of this research are to understand the molecular mechanisms by which H. pylori infection can lead to disease, and to understand the basis for variation in clinical outcomes among H. pylori-infected persons.